Clinical Therapeutics

PROJECT SUMMARY/ABSTRACT
The postdoctoral training program in Clinical Therapeutics is the core function of the Committee on Clinical
Pharmacology and Pharmacogenomics (CCPP) at The University of Chicago (UC) and the educational
component within the Center for Personalized Therapeutics (CPT). The program provides an infrastructure for
the postdoctoral training of both clinicians and translational scientists in clinical pharmacology, therapeutics,
and pharmacogenomics. The CCPP is a formal interdepartmental unit that is responsible for the training
program, which is accredited by the American Board of Clinical Pharmacology (ABCP). M. Eileen Dolan, PhD
(Chair of CCPP) directs the program along with Mark Ratain, MD (Director, CPT and the ABCP-accredited
training program) and Peter O'Donnell, MD (Deputy Director, CPT). The CCPP leadership team is assisted by
an Executive Committee, a Fellowship Selection Committee, and External Advisory Committee. The program
fulfills a unique niche within UC, providing focused training in translational pharmacology to trainees with either
a clinical or scientific background (some trainees have both a clinical and PhD degree). Although the primary
mission is to prepare clinicians for an academic research career in clinical pharmacology, the program also has
successfully trained scientists for careers in government and the pharmaceutical industry. Most trainees have
medical degrees and are board eligible in their area of specialty; other trainees hold PharmD or clinical PhD
degrees (e.g., psychology,. We offer numerous opportunities for dual training with many departments within the
UC community including the Department of Medicine's section of adult hematology/oncology, rheumatology,
pediatric hematology/oncology, and psychiatry and a new collaboration with pathology. We will be offering joint
training in Clinical Chemistry/Clinical Therapeutics and Clinical Informatics/Clinical Therapeutics.
In all disciplines, the program is primarily focused on research training, under the supervision of a mentor
selected by the trainee (and approved by the Executive Committee) and is supplemented with formal
coursework and participation in seminars, career and leadership development, and teaching. Clinical training
includes participation in our Personalized Therapeutics Clinic, the Institutional Review Board, the Clinical Trials
Review Committee and the Pharmacy and Therapeutics Committee. Trainees submit abstracts and attend the
annual American Society for Clinical Pharmacology and Therapeutics meeting. A maximum of 10% effort is
allowed for clinical responsibilities in the area of the trainee's specialty. Upon completion of this program, the
trainee is expected to become accomplished in basic research methodology, experimental design, and data
interpretation and presentation, and be prepared for a competitive research career in clinical therapeutics, as
well as certification in Clinical Pharmacology.

Public health relevance
PROJECT NARRATIVE The postdoctoral training program in Clinical Therapeutics is the core function of the Committee on Clinical Pharmacology and Pharmacogenomics at The University of Chicago and the educational component within the Center for Personalized Therapeutics. The program provides an infrastructure for training of both clinicians and translational scientists in clinical pharmacology, therapeutics, and pharmacogenomics. Upon completion of the program, trainees are expected to become accomplished in basic research methodology, experimental design, and data interpretation and presentation, and be prepared for a competitive research career, as well as certification in Clinical Pharmacology (licensed physicians) or accredited in Applied Pharmacology (non- physicians or non-licensed physicians) by the American Board of Clinical Pharmacology.